The role of GATA2 in myeloid malignancies and MonoMAC syndrome

PROJECT SUMMARY/ABSTRACT
The long-term goal of this project is to better define the role of GATA2 in the pathogenesis of acute
myeloid leukemia (AML) and the MonoMAC syndrome, and to use this information for therapeutic
benefit. Somatic GATA2 mutations occur in -3-4% of AML cases, and inherited mutations are the cause of the
MonoMAC syndrome, which is associated with the development of AML in most patients. We recently showed
that Gata2 can act as a tumor suppressor in AML. However, the mechanisms by which GATA2wr and GATA2
mutations influence AML pathogenesis are currently unclear. In preliminary studies, we found that AMLassociated
GA TA2 mutations dysregulate gene expression, and alter GAT A2 protein interactions. Based on
these findings, we hypothesize that GATA2wr normally acts as a tumor suppressor as part of an
interacting set of proteins that regulate a specific set of target genes; GA TA2 mutations may promote
AML and MonoMAC by altering these functions, We will test these hypotheses via the following aims:
Specific Aim 1: We will define the genes that are regulated by Gata2wr, and how their expression is
altered by AML- and MonoMAC-associated Gata2 mutations, We generated a novel Gata27354M knock-in
mouse- the first to model a MonoMAC- and AML-associated GATA2 mutation. In preliminary studies, we used
single-cell RNA sequencing (scRNA-seq) and flow cytometry to find that these mice have decreases in key
hematopoietic populations similar to that of the MonoMAC syndrome. ScRNA-seq also allowed us to identify
346 genes that are differentially expressed in myeloid progenitor cells from Gata2'354M mice vs. littermates. The
Gata27354M mice will be fully characterized for changes in hematopoiesis and AML development We will also
use an overexpression model to define alterations in gene regulation caused by other AML-associated Gata2
mutations including A318V, L321 F, T354M, and R362G in human and mouse hematopoietic stem/progenitor
cells (HSPCs). If successful, these studies will allow us to identify the genes that are regulated by Gata2wr in
primary HSPCs, and to determine pathways that are disrupted by Gata2 mutations.
Specific Aim 2: We will identify the GATA2 protein "interactome", and how it is altered by AML- and
MonoMAC-associated GATA2 mutations, We developed a proximity labeling system in which the Gata2
cDNA is fused to an enhanced biotin ligase, called "TurbolD". GATA2-TurboID biotinylates proximal proteins,
allowing for the identification of interacting proteins by mass spectrometry. In preliminary studies, we identified
the protein "interactome" of GA TA2wr in primary mouse and human HSPCs, and determined that GATA2T354
M
alters many of these interactions. We will apply this system to study how other GATA2 mutations (A318V,
G320D, L321 F, R362G, and R398W) affect protein interactions. Co-immunoprecipitation assays in HSPCs
from Gata27354M mice will be used to orthogonally validate our results. If successful, these studies may reveal
mutant GAT A2 protein interactions that can be targeted with novel therapeutic approaches to treat AML.

Public health relevance
PROJECT NARRATIVE The proposed studies seek to identify the molecular mechanisms by which wild-type GATA2 and GATA2 mutations regulate myeloid malignancies and the MonoMAC syndrome. The knowledge gained from these studies could potentially reveal target gene expression and protein interactions that are altered by GA TA2 mutations. This proposal is a part of a broader strategy to identify and functionally validate the GATA2 target genes and protein interactions that are functionally relevant for the pathogenesis of myeloid malignancies and the MonoMAC syndrome, and to develop novel ways to manipulate these pathways for therapeutic benefit.